The University of Kentucky Cancer Nanotechnology Training Center (UK CNTC)

DESCRIPTION (provided by applicant): The University of Kentucky Cancer Nanotechnology Training Center (UK CNTC) will provide advanced multidisciplinary training for predoctoral students and postdoctoral fellows toward the goal of creating a new type of cancer researcher who is skilled and ready to pursue a career in cancer nanotechnology research. Nationally and internationally recognized faculty members at the University of Kentucky will collaborate to create a fertile environment for the novel exploration of nanotechnology and cancer. Expertise covers a broad multidisciplinary range of scientific areas in gastrointestinal cancer, lung cancer, gliomas, radiation medicine, surgery, cancer screening, imaging, and pharmacokinetics and dynamics. Among these faculty are 16 nanotechnology researchers in the Departments of Chemical Engineering, Materials Engineering, Electrical Engineering, Chemistry, and Pharmaceutical Sciences and 18 biomedical scientists or clinical oncologists in the Colleges of Pharmacy or Medicine. Based on existing research collaborations, we propose cancer nanotechnology projects composed of multidisciplinary focus area teams with the goal of training future leading researchers in the field of cancer nanotechnology in the following four areas: (1) early detection and diagnosis in lung, colon, and ovarian cancer; (2) treatment of gastrointestinal tumors and metastases; (3) lung cancer treatment; and (4) glioma therapy. Specific Aim 1 is to expand the core expertise of participants in the UK CNTC through cross-disciplinary laboratory research training projects of up to two years involving innovative applications of nanotechnology to address specific unmet needs in cancer detection and therapy. Our trainees will be at the forefront of research that will be driven toward developing novel cancer therapies and diagnostic strategies based on nanotechnology. Through these activities, the trainees will obtain a detailed understanding of the molecular basis of cancer, the unresolved clinical problems in treating and diagnosing the disease, and acquire expertise in the field of nanotechnology. In Specific Aim 2, the CNTC will provide trainees with problem-based and experiential training through seminars, workshops, short courses, clerkships, and laboratory training modules that will build their research skills and confidence as members of multi-disciplinary research teams. Each trainee will be immersed in individualized problem-based instruction and a broad multidisciplinary training through core courses, short courses, participation in seminars, undergraduate and early graduate student mentoring, and outreach activities designed to educate the public. Trainees will be guided through these programs with effective mentorship and an evaluation program (Specific Aim 3) that will assess the effectiveness of trainee progress and development. Finally, Specific Aim 4 is to highlight the accomplishments of CNTC trainees both regionally and nationally. As such, our trainees will learn to envision, articulate, and perform nanotechnology-centered research focused on developing novel solutions to the outstanding clinical problems associated with cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: The University of Kentucky Cancer Nanotechnology Center will provide a systematic and unique multidisciplinary training environment, focusing on laboratory hands-on research, to create a workforce capable of using nanotechnology for solving intractable cancer research problems. Trainees of the Center will be immersed in a research environment designed to take advantage of the multiple research strengths of faculty at the University of Kentucky and will emerge with a broad yet detailed knowledge of cancer diagnostics, interventions, and related nanotechnology applications including drug delivery, early detection and treatment. The University of Kentucky Cancer Nanotechnology Center will provide a systematic and unique multidisciplinary training environment, focusing on laboratory hands-on research, to create a workforce capable of using nanotechnology for solving intractable cancer research problems. Trainees of the Center will be immersed in a research environment designed to take advantage of the multiple research strengths of faculty at the University of Kentucky and will emerge with a broad yet detailed knowledge of cancer diagnostics, interventions, and related nanotechnology applications including drug delivery, early detection and treatment. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The UK Cancer Nanotechnology Training Center (UK CNTC) will provide advanced multidisciplinary training for predoctoral students and postdoctoral fellows in a highly collaborative environment comprised of eminent faculty and productive laboratories in four Colleges located in close proximity to each other on one campus. The 34 faculty members include 16 nanotechnology researchers in the Departments of Chemical Engineering, Materials Engineering, Electrical Engineering, Chemistry, and Pharmaceutical Sciences and 18 biomedical scientists or clinical oncologists in the Colleges of Pharmacy or Medicine with expertise in gastrointestinal cancer, lung cancer, gliomas, radiation medicine, surgery, cancer screening, imaging, and pharmacokinetics and dynamics. Multidisciplinary focus area teams are proposed which build on relationships already developed among the faculty through existing collaborations. Our overall goal is to foster the development of a new genre of cancer nanotechnology researcher who will fully appreciate the breadth of disciplines involved in translating novel laboratory findings to cancer diagnosis and treatment. This will be accomplished through their immersion in cross-disciplinary mentored laboratory training projects, individualized problem-based instruction and focused laboratory training, participation in seminars, undergraduate and early graduate student mentoring, and outreach activities designed to educate the public. Trainees will acquire a clear understanding of the molecular basis of cancer and the unresolved clinical problems plus sufficient expertise in nanotechnology to envision, articulate, and carry-out research to find realistic nanotechnology solutions to these problems. Aim 1: Expand the core expertise of participants in the UK CNTC through cross-disciplinary laboratory research training projects of up to two years involving innovative applications of nanotechnology to address specific unmet needs in cancer detection and therapy. We envision a steady-state of 8 trainees at any given time, with 6 advanced predoctoral participants and 2 postdoctoral fellows. Participants may have basic science, applied science, or clinical backgrounds (i.e., PharmD and MD residents). Two of the predoctoral trainees will be supported by matching funds provided by the Markey Cancer Center. Based on his or her specific training and interests, each participant will become an active member of one of four collaborative teams seeking nanotechnology solutions in: (1) early detection and diagnosis in lung, colon, and ovarian cancer; (2) treatment of gastrointestinal tumors and metastases; (3) lung cancer treatment; and (4) glioma therapy. The nanotechnology faculty members of these focus area teams have particular strengths in molecular imaging and early detection, in vivo nanotechnology imaging systems, multifunctional therapeutics, and research enablers, all of which have been identified as critical nanotechnology platform needs in the mission statement of the NCI Alliance for Nanotechnology in Cancer. Aim 2: Provide trainees with problem-based and experiential training through seminars, workshops, short courses, clerkships, and laboratory training modules that will build their research skills and confidence as members of multi-disciplinary research teams. Depending on their backgrounds, predoctoral students tracking into the CNTC program will be required to complete certain core courses as pre- requisites to diversify their backgrounds (e.g., a nanotechnology or cancer biology course). During the program students will receive training in ethics and grant writing. In addition, participants will select a set of short courses, hands-on lab modules, clinical rotations, etc. tailored to their research project and focus area, backgrounds, and interests. All trainees and mentors will be expected to participate in a combined CNTC/Experimental Therapeutics research seminar. Aim 3: Evaluate the progress of CNTC participants and the effectiveness of the program. Trainee progress will be evaluated on a regular basis to ensure that the trainee and the program are meeting their objectives. The participants will work with their primary mentor and focus area team co-mentors to prepare written goals with milestones that will be reviewed and updated during monthly meetings with the team. The Mentoring and Development Committee will meet with trainees at six-month intervals to monitor the trainee's progress and to invite suggestions from the trainee on ways to improve the program. A written evaluation and summary of the participant's comments will be prepared and discussed with the participants' mentors. Aim 4: Highlight the accomplishments of CNTC trainees both regionally and nationally. CNTC trainees and participating faculty will be expected to present their research findings at international, national and local basic science and clinical conferences/meetings and publish in appropriate scientific journals. We will establish a dedicated website for our program and the websites of our affiliate Outreach programs will provide links to our announcements and archived information. CNTC trainees will be expected to participate in 20 hours of outreach and mentoring activities during their training period and feedback on their performance will be provided.